Human DNA Translesion Synthesis Polymerase kappa

Project highlights: the primary qHTS screen has been completed, and follow-up cherry picks were tested in a panel of different TLS polymerases and DNA modifying enzymes for final compound selection. Further compound validation is ongoing in cell and gel-based assays. During this period, the NCGC has fostered and maintained over 180 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to over 100 high-throughput screens and nearly 60 medicinal chemistry campaigns, providing our collaborators and the general research community a wealth of publications and promising small molecule leads. In addition, the NCGC has undertaken a number of informatic challenges to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.